Nanoparticle formulation of Mediator kinase inhibitor for the treatment of peritoneal ovarian cancer

Metastatic ovarian cancers (OC), the second most common gynecological malignancy, is a lethal disease, the
treatment of which still relies primarily on conventional cytotoxic drugs. Metastatic OC in most patients is localized
to the peritoneal cavity, including the peritoneum and omentum along with malignant ascites, making this cancer
the primary target disease for intraperitoneal (IP) chemotherapy. Nevertheless, even IP therapy eventually fails
in peritoneal OC, and new targeted drugs against the metastatic disease are urgently needed. We have found
that non-toxic small-molecule inhibitors of transcription-regulating Mediator kinases CDK8/19, which are
currently being developed as oral drugs for other cancers, are efficacious against metastatic tumors of different
cancer types. In particular, SNX631-6, the current Mediator kinase inhibitor drug candidate, inhibits peritoneal
growth of different types of OC, when given orally as a single oral agent or in combination with cisplatin. Since
IP drug delivery offers a pharmacokinetic advantage over oral drug administration resulting from the peritoneal-
plasma barrier, we expect that IP delivery of SNX631-6 should greatly increase its efficacy against peritoneal
OC. However, this drug is poorly soluble at neutral pH and precipitates when administered IP. To overcome this
problem, we have now developed a novel, stable and homogeneous nanoparticle formulation of SNX631-6,
which provides favorable plasma pharmacokinetics upon IP administration. The goal of this Phase I STTR
proposal is to optimize the nanoparticle formulation of SNX631-6 for IP delivery and to test its efficacy in
peritoneal models of different subtypes of OC. To this end, we will generate and test nanoparticles based on
copolymers with varying block lengths and structures and test the nanoparticles in regard to their size distribution,
shape, stability at different temperatures, cell-based potency and lack of off-target cytotoxicity. Nanoparticles
with the best characteristics will be analyzed for their plasma pharmacokinetics at different doses and tested for
increased accumulation in perioteoneal OC tumors upon IP delivery, relative to orally administered SNX631-6.
We will also analyze the safety and toxicokinetics of the IP-delivered nanoparticle formulation of SNX631-6 in
mice. The optimized nanoparticle formulation of the Mediator kinase inhibitor will be tested for the suppression
of peritoneal tumors formed by different types of OC, in parallel with orally delivered SNX631-6, to determine if
the IP-delivered nanoparticles improve the efficacy of SNX631-6 relative to the oral drug, and if the response to
Mediator kinase inhibition varies among different types of peritoneal OC. Transcriptomic analysis will be
conducted to identify transcriptomic markers of the response of peritoneal OC to Mediator kinase inhibition. The
future Phase II program envisions the identification of the optimal combinations of IP-delivered Mediator kinase
inhibitor with standard-of-care chemotherapeutic drugs for the treatment of peritoneal OC and the development
of SNX631-6 nanoparticles towards clinical trials in patients with the metastatic OC.

Public health relevance
Ovarian cancer is the second most common gynecological malignancy, the treatment of which still relies primarily on conventional cytotoxic drugs. Metastatic ovarian cancer, which in most patients is localized to the abdominal cavity, remains a lethal disease. This proposal aims to develop a novel nanoparticle form of an experimental drug developed to suppress metastatic tumors, and to test the efficacy of these nanoparticles in animal models of metastatic ovarian cancer.